Defining mucosal plasma cell origin, residence, and longevity in the upper airway

The upper respiratory tract is lined by two distinct mucosal tissues. Respiratory mucosa
humidifies and modulates incoming air temperature as it passes toward the lungs. Olfactory
mucosa on the other hand is specialized for chemosensation and supports detection of airborne
odorants by olfactory sensory neurons (OSNs). We have recently described an endothelial level
barrier, a “blood-olfactory barrier” (BOB), that prevents high molecular weight proteins like
antibodies (~150kD) from accessing the olfactory mucosa. Antibodies are absolutely required to
prevent olfactory reinfection by airway viral infections, but serum neutralizing antibody provides
no protection. Our studies have found that antibody secreting plasma cells (PCs) must reside
within olfactory tissues- beyond the BOB- to provide locally neutralizing antibody in order to
prevent olfactory infection. While vaccines generate robust circulating antibody titers, we found
that they generally fail to differentiate OlfPC and as such, fail to protect against olfactotropic
pathogens (that infect the olfactory mucosa), including SARS-Cov-2. Tissue specific PCs are
generally understudied and this proposal will specifically establish a foundational understanding
of when OlfPCs establish tissue residence, how long and where they reside within olfactory
tissues, and how these cells relate to the peripheral BM PC pool. These data will empower
mechanistic improvements to vaccines against upper respiratory infection.

Public health relevance
Relevance: This proposal will provide foundational data about a recently characterized population of tissue resident antibody producing cells (Plasma cells, PC) that protect tissues without access to serum antibody. These tissue PC lie within the olfactory mucosa of the airway where they prevent replication and subsequent neuroinvasion by airborne infections. Defining the core features of these resident antibody producing cells and how they relate to systemic immune responses will provide important insight into vaccine design and global health.